Pediatric Infectious Diseases and Immunity Training Program

PROJECT SUMMARY
This application proposes the renewal of a post-doctoral training program in pediatric infectious diseases and
immunology (PIDI-TP), based in the Divisions of Pediatric Infectious Diseases (ID) and Rheumatology &
Immunology at Washington University School of Medicine (WashU) and St. Louis Children’s Hospital. The long-
term objective is to train academic physician-scientists to carry out impactful research in pediatric ID pathogenesis
and host response. WashU offers an outstanding training environment for physician-scientists, with nationally
recognized hospitals anchoring one of the nation’s premier biomedical research facilities. Many WashU faculty,
both within and outside the Department of Pediatrics, are field-leading investigators in infectious diseases and
human immunology. PIDI-TP will also take advantage of extensive WashU facilities for genome sequencing and
microbial genomics, as well as 100 other Research Cores. Our 45 PIDI-TP mentors, drawn from the Departments
of Pediatrics, Medicine, Molecular Microbiology, and Pathology & Immunology, represent highly successful
investigators with externally funded research programs and experience in mentoring physician-scientists. As
before, the PIDI-TP Program Director (PD) will be David Hunstad, MD, the Arnold W. Strauss Endowed Professor
for Mentoring, Professor of Pediatrics and Molecular Microbiology, and Chief of the Division of Pediatric ID. The
co-PD will be Megan Cooper, MD, PhD, the Anthony R. French Professor of Pediatrics, Professor of Pathology &
Immunology, and Chief of the Division of Pediatric Rheumatology & Immunology. Trainee selection and program
activities and outcomes will be overseen by an Executive Committee consisting of the two PDs and two other
tenured investigators at WashU who are heavily involved in physician-scientist training, and advised by external
faculty who are nationally recognized experts in pediatric ID and/or immunology and associated training programs.
Each trainee will be advised by an individualized Scholarship Oversight Committee (SOC) comprised of established
investigators with complementary expertise. The program will continue to support two postdoctoral (MD or
MD/PhD) trainees per year, to be recruited primarily from our pediatric fellowship programs in Infectious Diseases,
Rheumatology, and Allergy/Immunology, but also from Neonatology, Pulmonary Medicine, Nephrology, and Critical
Care, drawing in particular on MD/PhD trainees in our robust Physician-Scientist Training Program. The mentored
research experience, educational and career development activities for trainees are organized in three arenas:
Pathogens, Host, and Omics. A core curriculum for all participants will provide training in study design, biostatistics,
human subjects research, animal use and care, scientific writing, grant and manuscript preparation, genomics, and
the responsible conduct of research. Career development will be monitored by research mentors, the PDs, the
Executive Committee, and the SOCs. Program evaluation will rely on short-term and long-term metrics as well as
input from external reviewers and from current and past trainees.

Public health relevance
PROJECT NARRATIVE This postdoctoral training program will train academic physician-scientists to perform research in infectious diseases, microbiology, and immunology related to child health. Infectious diseases continue to cause extensive morbidity and mortality throughout the world, and trained researchers are needed who can apply powerful new scientific methods to combat these diseases. Accordingly, our trainees will employ the full array of cutting-edge and traditional approaches to understand the biology of established and emerging infectious diseases, genetically determined immune deficiency, and autoimmune diseases.